POSTOPERATIVE CARE OF THE LIVER TRANSPLANT PATIENT

To improve the understanding of the physiology and pathophysiology of the transplanted liver, thus improving the overall quality of life after transplantation and graft (and patient) survival.